Novel Computational Methods for Modeling Cytochrome P450 Mediated Drug Metabolism

DESCRIPTION (provided by applicant): The metabolism of drugs and other xenobiotics by cytochrome P450 enzymes (CYP) is an essential detoxification and drug clearance mechanism in humans. Despite the publication of several X-ray structures since 2000, reliable computational prediction of drug metabolism remains a huge challenge. In this grant application, we propose an integrative high-throughput approach that combines electronic properties of a ligand with structural properties of the protein. Our main aim is the development and application of innovative structure-based design techniques that address serious shortcomings of current approaches. In particular, we have extended our novel docking concept to incorporate all observed forms of protein flexibility relevant for ligand-CYP interactions, entropic contributions influencing the prediction of binding poses, and we will add on- the-fly solvation to ligand-CYP complexes. To improve the docking quality we will optimize the parameters of a scoring function tailor-made for each CYP enzyme studied. In combination with an initial focus on efficient calculation of hydrogen-abstraction energies we will predict regioselective metabolism of drugs or drug candidates binding to CYPs. Based on the resulting docking poses, multidimensional QSAR simulations will be performed for accurate quantification of binding affinity as a measure CYP-inhibition and better ranking of binding modes. The new computational methods will be applied to two CYP enzymes (CYP2C9, 3A4) important in drug metabolism. The generated computational models will be stored in a database and made publicly available. Other researchers will be invited to screen compounds against our CYP database via a secure Web protocol to predict drug metabolism and inhibition. The submission of data by other researchers will provide valuable feedback on the performance and applicability of the models.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cytochrome P450 mediated drug metabolism plays a critical role for the efficacy of administered drugs. This project is aimed toward developing and applying innovative computational methods to efficiently predict drug metabolism as well as inhibition of the drug metabolizing enzymes. The resulting computational models allow for the estimation of drug efficiency and the potential of adverse reactions early in drug discovery and thus have a strong impact on drug development. PROJECT NARRATIVE Cytochrome P450 mediated drug metabolism plays a critical role for the efficacy of administered drugs. This project is aimed toward developing and applying innovative computational methods to efficiently predict drug metabolism as well as inhibition of the drug metabolizing enzymes. The resulting computational models allow for the estimation of drug efficiency and the potential of adverse reactions early in drug discovery and thus have a strong impact on drug development. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Since the first publication of a mammalian cytochrome p450 enzyme (CYP) X-ray structure in 2000, structure- based computational approaches have become important tools in the prediction of phase I drug metabolism. Although standard modeling and simulation methods brought insight to many facets of the metabolism of xenobiotics, reliable computational prediction of drug metabolism remains a huge challenge. This is especially true for the promiscuous CYP enzymes such as CYP3A4 and CYP2C9. Experimental and computational studies have suggested that induced protein fit, solvation, and entropic contributions play a significant role in ligand binding to CYPs. We aim to develop novel and innovative computational approaches for docking and quantifying ligand binding affinities CYPs that incorporate these crucial factors. Aim 1: Building on our novel computational approaches to predict drug metabolism and inhibitor binding. Using our novel docking method that incorporates protein flexibility on various levels, such as loop flexibility, and also includes estimates for ligand entropy, we will predict CYP-ligand binding. We plan to extend our methodology to address serious shortcomings of current approaches: [Previous Aim 1a has been removed due to completion, see preliminary data] a) Inclusion of solvation effects in CYP-ligand binding. Explicit water molecules will be added on-the-fly during ligand docking to incorporate water-mediated interactions critical for protein-ligand stability. b) Efficient calculation of hydrogen-abstraction energies to predict metabolic sites. We will establish a consistent database of functional groups and their associated hydrogen-abstraction energies. Estimates of new functional entities will be based on quantum-chemical calculations. A descriptor for conformational effects will be added. c) Optimization of CYP scoring function. Available scoring functions represent a collection of empirical terms designed to give acceptable results for many different types of protein systems. We propose the design of a tailor-made scoring function whose individual terms are optimized specifically for CYPs. d) Docking in combination with multi-dimensional QSAR for a more accurate ranking of binding modes and for reliable prediction of binding affinities as an estimate for the potential of adverse drug-drug interactions. Aim 2: Databank of CYPs for screening. Our new computational approaches will be applied to two CYP enzymes relevant to drug metabolism. The associated computational models will be stored in a database and made publicly available for virtual screening of drug candidates via a secure Web protocol. The necessary computational infrastructure will be set up and maintained. Based on this infrastructure we will initiate an open collaboration platform with all interested academic and selected industrial research groups. [Previous Aim 3 has been removed to focus the scope of this proposal.]